Aspects of Biotin Nutrition

Long term goals of this project are to determine the biotin requirements for normal individuals and for individuals in circumstances in which biotin status may be impaired and to investigate the consequences and pathogenic mechanisms of marginal biotin deficiency.We recently demonstrated that marginal biotin deficiency is common during normal human gestation and have demonstrated that marginal deficiency is quite teratogenic in mice. Thus, the following five specific aims are relevant and timely. In Specific Aim #1, we will test the hypothesis that maternal biotin deficiency causes abnormal development of fetal skeleton and palate by causing deficient fetal activity of the biotin-dependent enzyme acetyl-CoA carboxylase which leads in turn to deficiency of arachidonic acid and prostaglandin. In fetal palate and limb bud explants from biotin deficient and sufficient CD-I mice, we will quantitate fetal arachidonic acid content and synthesis rates and will examine the malformation ameliorating effects of supplementation of arachidonic acid and prostaglandin and the amelioration blocking effects of cyclooxygenase inhibitors. Analogous studies will also be conducted in vivo; In Specific Aim #2, we will test the hypothesis that infants with cleft palate or limb shortening have significantly reduced biotin status compared to normal infants. In a case-controlled study, biotin status will be assessed in cord blood using odd-chain fatty acid composition in red blood cell membranes and plasma and lymphocyte activity of the biotin-dependent enzyme propionyl-CoA carboxylase. In Specific Aim #3, we will clone and sequence a biotin transporter recently discovered in our laboratory. In studies of cells from the first individual with biotin transporter deficiency, we will investigate the molecular nature of the genetic defect. In Specific Aim #4, we will confirm promising new indicators of biotin status and investigate the validity of the expression of particular biotin-related genes (e.g., carboxylases) as indicators of marginal biotin deficiency in healthy adults rendered marginallybiotin deficiency by egg-white feeding. In Specific Aim #5, we will determine the subcellular localization of the enzyme(s) responsible for catalyzing the p-oxidation of biotin to the inactive metabolite bisnorbiotin and characterize this pathway. Understanding of this pathway is important because accelerated biotin catabolism may be the major cause of biotin deficiency in pregnancy and anticonvulsants. PERFORMANCE snt(S) (organization, city, state) University of Arkansas for Medical Sciences, Little Rock, AR General Clinical Research Center, McClellan Veteran's Hospital, Little Rock, AR KEY PERSONNEL. See instructions on Page 11. Use continuation pages as needed to provide the required information in the format shown below. Name Organization Role on Project Donald M. Mock Univ. Arkansas for Medical Sciences Principal investigator PHS398 (Rev. 4/98) Page 2 BB cc Princip tigator/Program Director (Last, first, middle): MOC snald M. Type the rams of the principal investigator/pn 'director at the top of each printed page and each Onuafon page. (For type specifications, see instructions on page 6.) RESEARCH GRANT TABLE OF CONTENTS Page Numbers Face Page 1 Description,